The MetaCyc & BioCyc Pathway/Genome Databases

7 Project Summary The project objective is to develop a bioinformatics foundation for deciphering and modeling the metabolic networks of organisms with fully sequenced genomes, in support of drug discovery, metabolic engineering, systems biology, and basic science. Our approach is based on a gold-standard metabolic DB, MetaCyc, which is curated by Ph.D.-level biologists, from the experimental literature. A second objective is to further develop BioCyc, an evolving collection of Pathway/Genome Databases for 14,560 sequenced prokaryotic genomes. BioCyc is a premier prokaryotic genome web portal because of its comprehensive coverage of prokaryotic genomes; its integration of multiple information sources; its extensive and user-friendly bioinformatics search, visualization, and analysis tools; and its distribution of data via multiple access channels. We have four specific aims. (1) To expand MetaCyc, a highly curated multi-organism database of metabolic pathways and enzymes that serves as an encyclopedic reference of metabolic information. MetaCyc can be used to predict the metabolic pathway complement of an organism from its sequenced genome, and is a foundation for metabolic modeling. Information about experimentally determined metabolic pathways and enzymes will be curated into MetaCyc from the biomedical literature, with a focus on prokaryotic pathways. (2) To computationally generate extended versions of BioCyc, a collection of organism-specific Pathway/Genome Databases for completely sequenced prokaryotes and model organisms that includes predicted metabolic pathways, predicted metabolic pathway hole fillers, and predicted operons. We will curate the human metabolic database within BioCyc, as well as databases for important organisms in the human microbiome. (3) To enhance the PTools software that supports the querying, visualization, and analysis of MetaCyc and BioCyc data to include a more accurate metabolic pathway prediction algorithm, a new visualization of genome-scale metabolic networks, and a new set of comparative operations. We will also enhance the scalability of the software, and modernize its graphics. (4) To make MetaCyc and BioCyc available to the scientific community through a web portal and via downloadable data files and software.

Public health relevance
8 Project Narrative This project will create a powerful and user-friendly web portal containing thousands of bacterial genomes, together with the biochemical pathways encoded by each genome. By characterizing the metabolic pathways of thousands of organisms, this project will facilitate alterations to those pathways by metabolic engineering, such as to enable bacteria to synthesize drugs and fuels. The project will also speed the development of drugs that kill disease- causing bacteria by enabling identification of essential metabolic pathways for disruption.